Socio-cultural and community risk and resilience for alcohol related problems in youth

PROJECT SUMMARY/ABSTRACT. While alcohol remains the most widely endorsed substance during
adolescence, and various psychosocial risk factors have been identified, unknown are the potential origins for
how disparities in alcohol related problems emerge among young adults among Hispanic/Latina/x/o
populations. Applying a health disparities approach to youth alcohol use (AU) prevention research is necessary
to identify high impact points of intervention during adolescence before AU related problems emerge in
adulthood. Given that health disparities are attributable to compounded exposure to adversity beginning in
childhood, investigating relationships between the social determinants of health (SDoH) and AU and related
problems in adolescence is critical. We will consider both the risk and protective role of socio-cultural factors
(e.g., discrimination vs. familism) for AU and mental health during adolescence using the ecodevelopmental
framework, with a focus on Hispanic/Latina/x/o youth. Further, understanding SDoH (e.g., school and
neighborhood features) associations with AU and related problems will guide policy to identify upstream
determinants that can be intervention targets to bring systemic change that reduces health disparities. This
proposal will leverage the Adolescent Brain Cognitive Development® (ABCD) Study, a large comprehensive
dataset, to advance critical areas of research in AU prevention with a focus on Hispanic/Latina/x/o youth and
intersecting identities (e.g., gender and generational status). A quantitative analysis will test (1) socio-cultural
determinants of AU related problems and mental health, and (2) AU influences on mental (anxiety/depression)
in association with cognitive and school performance in Hispanic/Latina/x/o youth. This proposal will use ABCD
study longitudinal data to identify promotive socio-cultural factors (i.e., high familism and low discrimination)
that may buffer risk for AU and related problems influenced by both risk from individual and broader social-
cultural contexts (i.e., school and neighborhood). Potential co-emerging disparities in mental health among
youth will be investigated, and whether mental health (i.e., anxiety/depression) outcomes moderate (i.e.,
exacerbates) the influence of AU on adolescent cognitive functioning. This proposal will then extend the
application of the SDoH framework with community-engaged research approach to conduct a qualitative study
with focus groups with Hispanic/Latina/x/o youth and parents and obtain a response to the ABCD study
quantitative findings to identify research gaps and priorities for AU related problems in the Hispanic/Latina/x/o
community. Findings will inform hypotheses on future AU prevention research using community-engaged
approaches with Hispanic/Latina/x/o youth in a future R01. In summary, the quantitative and qualitative studies
proposed will investigate the socio-cultural determinants of potential co-emerging disparities in alcohol use and
mental health and subsequent impact on cognitive development, with a focus on Hispanic/Latina/x/o youth.
Findings will inform future interventions on AU prevention on timing and the interplay of socio-cultural contexts.

Public health relevance
Project Narrative The proposed project will investigate the intersection of socio-cultural determinants of alcohol use and related problems in youth, focusing on Hispanic/Latina/x/o youth, to identify factors of risk and resiliency. Given that health disparities emerge in childhood and can result from systemic inequities, this project will investigate how youth alcohol use and mental health intersect to exacerbate or buffer subsequent influences on neurocognitive and school performance in youth.